Continued Pressure for Alveolar Protection: A Randomized Controlled Trial (CPAP Trial)

PROJECT SUMMARY/ABSTRACT
Bronchopulmonary dysplasia (BPD) affects 50% of all preterm infants <29 weeks’ gestation and is
associated with long-term respiratory morbidity, neurodevelopmental impairment, and mortality. With
improving survival of more preterm infants caused by advances in neonatal care, the rates of BPD and post-
prematurity respiratory disease (PPRD) are increasing. Longer-term lung health trajectories and pulmonary
function among survivors of prematurity have also not improved in recent decades. CPAP is among the most
commonly used modes of respiratory support for very preterm infants that minimizes exposure to ventilator-
associated lung injury. Substantial animal data indicate that CPAP-induced mechanical strain promotes
compensatory lung growth in neonatal models of lung disease. Furthermore, recent clinical data suggest that
extending CPAP for 2 additional weeks among very preterm infants meeting criteria for CPAP cessation
increases lung and alveolar volumes and may improve short-term pulmonary outcomes. It is thus important
to test extending the duration of CPAP in a sufficiently large population of preterm infants at highest risk of
adverse outcomes to provide robust data to determine the benefits and risks of such a strategy. To address
this unmet clinical need, we will conduct the Continued Pressure for Alveolar Protection: A Randomized
Controlled Trial (CPAP trial), a scientifically rigorous multicenter trial among infants <29 weeks’ gestation and
<32 weeks’ post menstrual age (PMA) who meet typical criteria for CPAP cessation to determine whether
extending CPAP until 34 weeks’ PMA or for at least 2 additional weeks compared with weaning to nasal
cannula reduces respiratory morbidity. We will test the following two hypotheses that extending CPAP until
34 weeks’ PMA or for at least 2 additional weeks will (1) decrease BPD or death at 36 weeks’ PMA and (2)
decrease PPRD at 22 to 26 months follow-up. Our study is powered to detect a clinically meaningful
reduction in rates of BPD or death using a five-level ordinal outcome. PPRD will be assessed using a
modified ISAAC (International Study of Asthma and Allergies in Childhood) questionnaire at 22 to 26-months
follow up. The key innovation of this project is the application of extended CPAP, which may promote lung
growth in infants with lung disease who would usually be weaned to a nasal cannula. The Neonatal
Research Network has an excellent track record of enrolling high-risk infants in rigorous clinical trials of
respiratory interventions with successful participant retention at follow-up. Successful completion of this trial
will establish whether extending the duration of CPAP benefits extremely preterm infants compared with
weaning to nasal cannula, once typical CPAP cessation criteria are met, thus providing the data necessary
to inform key perinatal guidelines of respiratory support in very preterm infants. If extending CPAP reduces
respiratory morbidity in preterm infants <29 weeks’ gestation, this intervention could be readily implemented
worldwide among preterm infants with respiratory distress syndrome to improve future lung health.

Public health relevance
PROJECT NARRATIVE There are approximately 36,000 survivors of extremely preterm birth per year in the United States, and these infants have a high risk of chronic lung disease, asthma, and emphysema. Continuous positive airway pressure (CPAP) is commonly used in preterm infants with respiratory distress syndrome, and recent studies in preterm infants suggest that extending the duration of CPAP for at least 2 additional weeks may promote lung growth. This multicenter randomized clinical trial will test whether extending CPAP until 34 weeks’ postmenstrual age or for at least 2 additional weeks in preterm infants meeting typical criteria for CPAP cessation will reduce the risk of chronic lung disease.